PHASE I COCAINE DRUG INTERACTION STUDY. TO6. NIDA PHARMACOKINETIC ANALYSIS RESOURCE CENTER. 08/10/2023 - 02/09/2025. NIDA REF. NO. N01DA-19-8947.

PHARMACOKINETIC ANALYSIS RESOURCE CENTER (TRI)
The purpose of this order is to provide clinical support for a Phase 1 clinical pharmacokinetic trial of an
investigational agent aimed at treating cocaine abuse. This contract will provide medical writing, data management support, site monitoring, statistical analysis and pharmacokinetic analyses as well as study record management and archiving.